Core-003

Translational Endeavors encompasses two critical functions for the proposed CCTSI: the Translational
Workforce Development Program (TWD) and the Pilot Translational and Clinical Studies Program (PTC).
Success in clinical and translational science requires teamwork of individuals with complementary expertise.
The TWD program proposes high-performance oriented, competency-based training and preparation to create
a diverse, talented and committed workforce with the capacity to accelerate clinical translational science to
improve the health of society. The TWD will provide education and training along a pipeline of programs
beginning with students and trainees and extending to include career development for all faculty levels (instructor
to professor) and staff (any person working on clinical or translational research). We will achieve these goals
through the following Specific Aims: Aim 1: Develop and retain a highly qualified interdisciplinary team-focused
workforce prepared to conduct rigorous clinical translational research (CTR). Aim 1.1. Ensure that the entire
CTR workforce receives comprehensive training in Good Clinical Practice, Responsible Conduct of Research,
research ethics, and regulatory compliance. Aim 1.2. Enhance the CCTSI’s Workforce effectiveness as teams
by providing professional development initiatives in Team Science, Leadership and Mentorship. Aim 1.3.
Develop, pilot and evaluate a Career Ladder for Professional Research Assistants to standardize professional
development and competencies across their career trajectory. Aim 1.4. Close learning gaps identified by the
CCTSI Workforce by offering new educational programs in big data/informatics, entrepreneurship, and
dissemination and implementation sciences. The PTC Program will accelerate clinical and translational research
through a strategic pilot grant program designed to provide funding for innovative ideas, research methods and
collaborations by the CCTSI workforce. The Program will focus on the support of new research that will catalyze
the translation of scientific discoveries into treatments, develop new approaches to advance translational
science, promote community engagement in translational and team science and foster the development of young
investigators in clinical and translational research. We will achieve these goals through the following Specific
Aims: Aim 2: Implement a comprehensive Pilot Translational and Clinical Studies Program (PTC) to accelerate
high quality collaborative CTR throughout the CCTSI partner affiliates. Aim 3: Conduct rigorous, transparent
peer review of PTC applications to ensure that only projects with the greatest potential impact are supported by
the program. Aim 4: Establish and implement metrics that will be used to monitor the impact of the PTC. The
PTC will provide opportunities to address specific CCTSI priorities and open routes for innovative ideas and
development of novel technologies. The Program will promote all disciplines of research and will prioritize
research proposals that advance the science of translation. Program impact will be monitored both with NCATS
Common Metrics and with metrics developed to meet the needs of the PTC locally.